Administrative Core

Administrative Core Abstract
The PCHPI will establish an Administrative Core comprising the program co-directors, an executive committee,
a scientific advisory board, a PhD-level communications coordinator, financial administrators, and IT personnel.
The Administrative Core will be responsible for overseeing the center operations as a whole and for ensuring
progress toward our overall goals, considering the NIAID mission and the current state of HIV-1 structural
biology, as reported in the literature and through scientific symposia. Specifically, the Administrative Core will i)
establish and implement a robust management and intra-center communications plan; ii) draft, update and
implement strategic plans; iii) establish a versatile infrastructure and effective mechanisms for launching and
maintaining collaborations; iv) coordinate inter-center and extra-center communications and activities; and v)
ensure timely deposition of data in appropriate databases and repositories and facilitate data and resource
sharing with the community.